Dynamics, Regulation and Function of p53 in Single Cells

The dynamics of signaling systems are critical for controlling gene expression programs and cellular outcomes.
The tumor suppressor protein p53 is a transcription factor orchestrating the response to cellular stresses, and
we previously found that its dynamics (changes in its protein levels over time) following DNA damage depend
on the stimulus and play a role in determining whether a cell will survive or die. However, many questions remain
about how different cellular contexts influence p53 dynamics and ultimate cellular outcomes, how p53 chooses
between conflicting cellular outcomes, and how p53 dynamics can best be leveraged for therapeutic purposes.
The goals of our work are to obtain a comprehensive quantitative understanding of how p53 dynamics regulate
cellular outcomes in single cells and to apply our findings to address clinical needs. The cellular environment
can influence p53 dynamics, therefore we will first investigate how p53 dynamics are regulated by factors such
as 3D cellular architecture in cultured tumor spheroids and in in vivo tumors. We will then investigate the
dynamics and cellular outcomes of cancer-associated p53 mutants in cultured and in vivo settings. The effects
of p53 dynamical patterns on gene expression will be determined in single cells by using novel technology that
supports integrating live imaging data of p53 dynamics with single-cell RNA sequencing. We will also investigate
how p53 dynamics influence gene expression at the RNA and protein levels, as well as the dynamics of p53
post-translational modifications in bulk populations. These studies will reveal the impact that p53 dynamical
patterns have on the RNA and protein of its target genes, and how the combinations of these dynamical patterns
guide cellular outcomes. We will also use our live-imaging systems to determine how clinically-relevant
therapeutic approaches can be optimized to induce the desired p53 dynamics and cellular outcomes in cancer.
We will determine how the doses and timings of radiation fractions affect p53 dynamics and function, and
optimize the schedule of fractions for inducing tumor cell death via p53-mediated mechanisms. Many cancers
overexpress the p53 inhibitors Mdm2 or Mdmx and are susceptible to their inhibition. Through quantifying and
modulating p53 dynamics we will determine how to fine-tune their inhibition to sensitize Mdm2 or Mdmx
overexpressing cells to DNA damage while sparing healthy cells. Tumor cells can be cleared by the immune
system, and this process is influenced by the tumors' gene expression programs. Therefore, we will investigate
how p53 dynamics influence interactions between tumor cells and immune cells, and work towards optimizing
combinations of p53-targeting therapeutics with immunotherapies to maximize tumor cell killing by the immune
system. In total, these studies will provide new mechanistic insights into the links between p53 dynamics and
function in controlling cell fates, and will inform novel combinatorial therapeutic approaches to cancer treatments.

Public health relevance
Project Narrative Our study will provide new insights into the control and manipulation of the p53 pathway, one of the most important pathway protecting human cells against the development of cancer. Specifically, it will give a quantitative understanding of how p53 is controlled in individual cells; how it turns appropriate genes on and off, how this control is misregulated in cancers; and how therapeutic strategies to manipulate p53 activity can be combined with other cancer treatments to eliminate tumor cells. The knowledge gained from these studies will advance our understanding of how p53 operates in normal and cancer cells and help translate our insights to address important clinical needs.